Visual pattern representation in extrastriate cortex

Project Summary / Abstract
The goal of this research is to discover the cortical computations that determine the response properties of
neurons in visual cortical areas V2 and V4, two of the largest visual areas outside the primary visual cortex in
primates. V2 receives a strong direct input from V1, and depends on the functional integrity of V1 for its visual
responsiveness. We will therefore develop a two-stage model, in which responses are constructed from a
suitable combination of V1 afferents, with the design of each stage following a common canonical form. This
model is designed to account for the visual response properties of neurons as economically as possible,
allowing it to be fit to data recorded from single neurons. The model will also be able to generate population
representations that can predict perceptual capabilities. V4, in turn, receives the bulk of its direct input from V2.
We will measure V4 responses with the goal of building a similar model of the way it transforms input from V2.
Some neurons in V4 respond selectively to images of objects and shapes while others seem to be more
sensitive to local image statistics.
The motivation for the structure of the V2 model, and our confidence in its success, comes from the
convergence of three pieces of previous work: (1) we have developed, fit, and validated a similar two-stage
model for neuronal responses in area MT, an extrastriate area which also receives primary afferent drive from
area V1; (2) we have preliminary evidence for a key model element, which is to represent the operation of V2
neurons as derivatives over the space of its inputs, and (3) we have shown that models of this structure can
account for our previous discovery that many V2 cells respond more vigorously to naturalistic texture stimuli
than to matched noise. We will complement the modeling by analyzing the local structure of natural images
and the psychophysical performance of human observers in the space that the model is designed to capture.
We are not yet ready to build a principled model of how V4 combines inputs from V2. We believe that V4's
functional circuitry will be similar to that of V2, but in advance of the model we will build for V2 we lack a
sufficiently precise account of V4's inputs. But we have evidence from previous studies of V4 and from human
neuroimaging data that a key component of V4's response is its selectivity for complex forms, so we will make
measurements of V4 responses along a key image continuum between natural form and image statistics, and
will also measure the role of contextual signals in establishing V4's selectivity.
The outcome of this work will be a new understanding of the functions of V2 and V4, which plays a pivotal role
in the elaboration of visual information in the cerebral cortex.

Public health relevance
Project Narrative Disorders of the visual nervous system are a major cause of visual disability: Damage to the primary visual cortex (area V1) causes a loss of vision over part or all of the visual field, although parts of the visual cortex outside V1 may, in some cases, be able to substitute for some lost functions after V1 damage. Other disorders affecting these same areas outside V1 are associated with specific forms of visual loss such as akinetopsia (motion blindness) and agnosia (form blindness). Our research seeks to understand the organization and function of these cortical visual areas beyond area V1, which are of interest both because of their potential as a substrate for visual loss and recovery after brain damage, and because they are key parts of the processing chain by which sensory signals are transformed to form decisions, guide actions, and create enduring memories of evanescent events.